Core A: Administrative Core

The Administrative Core (Core A) has fulfilled three major functions during the current grant,
and will continue to do so in this renewal. One function is the overall management of the P01,
which is the responsibility of the PI, Steven Balk, with an administrator and in consultation with
the other PIs. This includes addressing all administrative issues, organizing group meetings,
organizing internal and external reviews, and in general facilitating communications and
collaborations. The second function of the Core has been to assist the Projects in efforts to
ensure that their laboratory studies and findings are physiologically significant, and ultimately to
translate their findings into patients. This has been facilitated by close interactions with our
clinicians, represented by our internal advisory board. Through previous/ongoing clinical trials
and tissue banking efforts at their respective institutions, these clinical investigators have
collected (and continue to collect) valuable samples from patients at varying stages of their
disease and after varying therapies. In discussions with the Project Leaders, they have provided
relevant clinical samples for analysis and have provided further insight into potential biological
significance of laboratory findings. The third Core function is to provide statistical support for
each of the Project Leaders in their experimental designs. The Specific Aims are 1) Provide
administrative support to insure that the goals of the project are achieved, 2) Assist in
translating the results from each Project into the clinic, 3) Provide biostatistical support for each
Project.

Public health relevance
The Administrative Core (Core A) is responsible for the overall management of the P01, including addressing all administrative issues, organizing group meetings, organizing internal and external reviews, and in general facilitating communications and collaborations. The second function of the Core is to assist the Projects in efforts to ensure that their laboratory studies and findings are physiologically significant, and ultimately to translate their findings into patients. The third Core function is to provide statistical support for each of the Project Leaders in their experimental designs.